Advanced Urinary Catheter for Reduction of Urinary Tract Infections and Improved Urologic Management

ABSTRACT ? “Development of Advanced Urinary Catheter for Reduction of Urinary Tract Infections and Improved Urologic Management” Catheter-associated urinary tract infections remain an outsized problem in healthcare systems worldwide. Individuals who rely on urinary catheterization for management of chronic urinary retention disorders are particularly susceptible to CAUTI because of their chronic usage. This SBIR Phase 1 proposal details plans by which to complete the prototyping, design refinement, and preliminary engineering validation of a new, fully internal male urinary catheter system. The Connected CatheterTM is an advanced urinary catheter designed to reduce the incidence of urinary tract infections (UTI), as well as to increase urological convenience and autonomy for males with urinary retention disorders. The Connected Catheter will be a chronically indwelling (maximum of 15-30 day service life) urethral catheter that resides fully internally, with its distal end in the base of the penile urethra. The catheter tip will incorporate a magnetically-actuated ball valve, which enables the bladder to fill naturally and the user to control voiding by applying a magnet to the base of the penis. The Connected Catheter aims to reduce the risk of catheter-associated UTI (CAUTI) via several mechanisms, including elimination of the trans-urethral-orifice span of standard Foley and the use of a unique Malecot retention mechanism that provides robust catheter fixation and complete bladder emptying while minimizing bladder lining abrasion and risk of genito-urinary trauma caused by Foley catheters. Relative to intermittent self-catheterization, the Connected Catheter aims to reduce the risk of both UTI and false passage (urethral puncture), as well as lower the associated cost of supplies, all by minimizing the number of self-catheterizations required. The Connected Catheter will offer increased comfort and convenience to all of its users, enabling natural bladder filling and easy voluntary voiding, all with a fully internal device that can be easily inserted and extracted by the user with a novel set of sterile-packaged, single-use insertion and extraction tools. The target deliverable of Phase 1 will be a complete bench-tested commercial prototype of the Connected Catheter system, suitable for subsequent validation and clinical testing in Phase 2. This proposed Phase 1 project is divided into four specific aims, including the successful fabrication, design optimization, and engineering validation of (1) the magnetically-actuated valve; (2) the catheter anchoring mechanisms; (3) the catheter insertion and extraction tools; and (4) the fully assembled product. Future development of the Connected Catheter system beyond the current project will include the development and incorporation of a wireless sensor capable of assessing bladder fullness, for users with neurogenic bladder dysfunction who lack bladder sensation.

Public health relevance
PROJECT NARRATIVE Urinary catheterization is the current standard of care for millions of American men with chronic urinary retention disorders, including benign prostate hyperplasia and neurogenic bladder dysfunction. However, current urinary catheter designs are plagued by a host of drawbacks and medical complications, including high urinary tract infection rates, genito- urinary trauma, and diminished patient quality of life due to inconvenience and discomfort. We are developing a solution that uses a fully-internal, valved catheter to reduce the number of times users have to catheterize themselves. By developing this product, we aim to reduce infections, reduce the costs of supplies and care, and improve patient satisfaction.